Structure-based strategy for developing inhibitors of the kidney chloride channel CLC-Ka

CLCs (the “Chloride Channel” family) are anion-selective transporters and channels ubiquitous in
all organisms. Among them, CLC-Ka and CLC-Kb are essential for Cl– and water handling in the
kidney. CLC-Ka is localized to the thin ascending limb, where it helps to establish the steep solute
gradient in the inner medullary interstitium that drives renal water reabsorption. As such, CLC-Ka
is a potential drug target for treating pathologic water retention (hyponatremia) that frequently
complicates the management of patients with hypertension, heart failure, or cirrhosis. A specific
CLC-Ka inhibitor would be invaluable for validating CLC-Ka as a drug target for manipulating renal
water excretion. In this project, we leverage recent breakthroughs to develop selective CLC-Ka
inhibitors. The first breakthrough is our discovery of BIM1, a substituted benzimidazole that
displays >20-fold selectivity for CLC-Ka over its closest homolog CLC-Kb. The synthetic
accessibility of BIM derivatives makes them well suited for further development. The second
breakthrough is the revolution in cryo-electron microscopy, which enables high-resolution
structure determination of challenging targets, including ion channels. A molecular structure of
the BIM/CLC-K complex will identify which regions of the BIM molecule must be retained for
potency/selectivity and which may be modified to improve pharmacokinetic properties. Guided by
this information, we will use a medicinal chemistry approach to develop BIM derivatives with
optimized potency, selectivity, and pharmacokinetic properties. Optimized BIM derivatives will be
tested for in vivo efficacy.

Public health relevance
PUBLIC HEALTH RELEVANCE: CLC channels are compelling targets for drug development, yet CLC pharmacology is undeveloped. The CLC-Ka inhibitors developed in this project will advance biomedicine by providing novel tools to investigate the function of CLC-Ka in the kidney and to advance new kidney therapies. The research results will provide a roadmap for further developing CLC pharmacology to treat kidney, muscle, bone, and neurological disease.